TRAJECTORY OF FATIGUE IN ADULT BREAST CANCER PATIENTS

Fatigue occurs frequently in people with cancer receiving chemotherapy, little is understood about the mechanisms of this phenomenon. In addition to describing the trajectory of fatigue in a specified patient population over a six-month period, this research will attempt to describe and correlate select physiological variables thought to influence the fatigue experience with an established fatigue scale.